Scaling up the brief alcohol intervention to prevent HIV infection in Vietnam: a cluster randomized, implementation trial

PROJECT SUMMARY
More than 25% of people with HIV (PWH) globally report unhealthy alcohol use, defined as a spectrum of use
from risky/hazardous (drinking more than the recommended daily, weekly or per-occasion amounts resulting in
increased risk for health consequences) to alcohol use disorder. PWH with unhealthy alcohol use may not
adhere to their antiretroviral therapy (ART), leading to unsuppressed virus and increasing the potential for HIV
transmission to sexual and injection partners. Interventions that address alcohol use among PWH are needed
to prevent HIV transmission. We previously showed that the brief alcohol intervention (BAI) is effective at
reducing alcohol use and increasing viral suppression in Vietnam. The BAI is ready for scale-up but one barrier
to scale-up is attitudes towards alcohol interventions among clinical staff, especially in regions with normative
unhealthy alcohol use. Addressing clinical staff attitudes may be essential for scale-up. We propose a hybrid
type 3, cluster randomized implementation trial to examine effective strategies to scale up the BAI in ART
clinics in Vietnam. One arm will receive only facilitation for BAI implementation. Facilitation is a flexible strategy
that helps clinics to address common barriers, such as counselor skills, competing priorities, and resource
deficits. In the other arm, in addition to facilitation, clinic staff, irrespective of their own alcohol use, will be
offered the BAI themselves as experiential learning to address their own alcohol-related attitudes and
behaviors. We hypothesize that EBAI, added to facilitation, will increase BAI fidelity, acceptability, and
penetration at the clinic level, and improve viral suppression among PWH with unhealthy alcohol use. Our
specific aims are to: 1) Compare BAI implementation using facilitation (FAC) only to experiential BAI plus
facilitation (EBAI+FAC) in ART clinics in Vietnam; 2) Explore the mechanisms of successful BAI scale up in
both the FAC and EBAI+FAC arms; and 3) Measure the impact of EBAI on clinic staff. ART clinics (n=30)
across Vietnam will be randomized to receive FAC or EBAI+FAC. PWH in the clinics will be screened for
unhealthy alcohol use with the AUDIT-C; if positive, they will be offered the BAI. The primary implementation
outcomes are clinic-level BAI fidelity (primary), with secondary outcomes of acceptability, penetration, and
cost. The effectiveness outcomes are viral suppression (primary) and alcohol use (secondary), measured
among a cohort of PWH recruited in each clinic. Outcomes will be measured at 3 months (implementation
outcomes only) and 12 months (all outcomes). In parallel with the trial, we will use mixed methods to examine
the organizational and clinic staff characteristics that underly successful BAI scale-up. Given the importance of
the clinic staff in the BAI implementation, we will also explore the impact of the BAI on their own alcohol-related
attitudes and use and considering whether they received the BAI themselves or not. This trial will present
critical information for worldwide HIV treatment as prevention efforts, providing strategies for effective scale-up
of the BAI among PWH with unhealthy alcohol use.

Public health relevance
PROJECT NARRATIVE The brief alcohol intervention (BAI) improves antiretroviral therapy adherence and increases viral suppression among people with HIV (PWH) with unhealthy alcohol use, reducing the possibility that they may transmit the virus. The BAI is ready for scale-up in ART clinics, but its effectiveness may be impaired by the alcohol-related attitudes and behaviors among clinic staff, especially in regions where excessive alcohol use is normative. This trial will identify the best way to scale up the BAI in ART clinics in Vietnam by giving some clinic staff the opportunity to experience the BAI themselves, before they are asked to give the BAI to PWH with unhealthy alcohol use.